Promoting HS Minority Advancement in the Social Sciences

DESCRIPTION (provided by applicant): The long-term goal of the proposed HS-COR Honors Research Training program is to achieve ethnic parity in admissions to (goal=100%) and success in undergraduate programs (goal = 100%) related to the biomedical sciences or mental health fields. Nationally, African Americans, Latin Americans, Native Americans, and some Asian Americans are underrepresented in the sciences and social sciences. The specific aims of the program are to increase underrepresented student success by: (a) identifying 6 students who appear to have the greatest potential, (b) training students in the fundamental assumptions, value of, and pitfalls of research, (c) facilitating students' specific research skills by their working with a faculty mentor on a specific research project, and (d) providing specific information and support to ensure that students have the qualities required to be successful in an undergraduate program, such as assistance with SAT preparation and the presentation of research in science fairs. Students will attend a summer training program on the research process that is designed to build scientific and critical reasoning skills and a practical seminar series and work one-on-one with their research mentors. Faculty mentors' research projects reflect a variety of areas including the neuropsychology of Alzheimer's disease, quality of life of elderly women, effects of stereotype threat on academic achievement of minority students, adolescent wellbeing, and violence prevention. Evaluation of three goals is specified. The goals are: (a) admission to college; (b) success while in college; and (c) professionalism. Each goal is made more specific and specific program components are matched with each goal.